Dynamic nanoscale cellular imaging via time-resolved cryo-vitrification

Summary:
Many cellular processes are triggered by ligands such as ions, small molecules, peptides/proteins (e.g.,
hormones, cytokines), and viruses. However, rapid cellular adaptations that follow stimulation often fall in the
blind spot of microscopy: limitations of spatiotemporal resolution prevent detailed exploration of nanoscale
cellular dynamics. Motivated by the need to address this technological barrier, we aim to develop a biophysical
tool that will allow stimulating biological cells with various chemical or biological compounds and then freezing
these cells for subsequent analysis by high-resolution microscopy. We refer to this technique by an acronym:
Vitrification Experiment Resolved In Time After Stimulation (VERITAS).
Broad utility of this new method in biological research is envisioned, including investigations concerning
the dynamics of cellular membranes and membrane-protein interactions, the dynamics of protein-protein and
protein-nucleic acid interactions, and the dynamics of post-translational modifications. In addition, the need for
the proposed instrument is supported by a user survey that we conducted.
Our approach is conceptually innovative because it will permit imaging of nanoscale cellular dynamics
with millisecond temporal resolution and because it establishes a connection between time-resolved
cryo-vitrification and super-resolved fluorescence imaging. The approach is methodologically innovative
because it will feature millisecond-level control over the stimulation-to-vitrification time, and reliable chemical
stimulation of cells. Moreover, we will develop new protocols to integrate cryo-vitrification and nanoscale optical
microscopy, and to validate the technique against live optical microscopy measurements.
In Aim 1, we will develop the time-resolved cryo-vitrification instrument by first achieving
millisecond-level control over the stimulation-to-vitrification time and then developing a method for precise
chemical stimulation of the sample. This work will complete our instrumentation development efforts and allow
proceeding to the validation stage.
In Aim 2, we will develop post-vitrification imaging and data analysis protocols and use these
procedures to validate VERITAS using two representative biological systems. These studies will test the
boundaries of utility of the method because they use different types of cells and different imaging methods.
Based on our preliminary data, the project is feasible. Our efforts will establish the groundwork for future
biological studies using the proposed time-resolved cryo-vitrification technique. We suggest that this is
significant because time-resolved cryo-vitrification will provide detailed molecular and structural understanding
of how cells respond to a variety of stimuli of relevance both to normal physiology and disease. Furthermore,
the proposal includes detailed plans for technology dissemination via direct collaboration, open-source sharing,
commercialization, and integration with local instrumentation facilities.

Public health relevance
Project Narrative and Public Health Relevance: We propose to develop a research instrument that will allow stimulating biological cells with various chemical or biological compounds and then freezing these cells for subsequent analysis by high-resolution microscopy. This instrument will be useful in studying how cells respond to hormones, neurotransmitters, drugs, viruses, and many other agents relevant both to human physiology and disease. The project integrates a series of conceptual and methodological innovations that will result in a novel approach to nanoscale imaging of normal and aberrant cellular dynamics.